Regulation of GLIS3, a Ciliary Transcription Factor that Prevents Kidney Cysts

ABSTRACT/PROJECT SUMMARY
This application presents a five-year mentored research and training plan that will prepare Dr. Gabriel Loeb to
lead a successful independent academic research program focused on the mechanisms underlying ciliary
kidney diseases. Dr. Loeb completed his MD and PhD at the Tri-Institutional MD-PhD Program at Weill Cornell
Medical College/Rockefeller University/Memorial Sloan Kettering where he studied the function of microRNAs
in the lab of Dr. Alexander Rudensky. Dr. Loeb completed his fellowship in Nephrology at UCSF and his long-
term career goal is to advance our understanding of the mechanisms underlying genetic forms of kidney
disease, particularly those caused by mutations in proteins that localize to primary cilia including Autosomal
Dominant Polycystic Kidney Disease and Nephronophthisis. This project will lay the foundation for his
independent research program, by dissecting ciliary pathways involved in kidney cystogenesis.
Mutation in either of two ciliary membrane proteins, PKD1 and PKD2, is responsible for most Autosomal
Dominant Polycystic Kidney Disease. However, the effectors of PKD1/PKD2 signaling remain unknown. GLIS3
is a transcription factor that localizes to primary cilia and the cell nucleus. Loss of GLIS3 phenocopies the
severe cystogenesis caused by loss of PKD1 or PKD2. These data suggest the hypothesis that GLIS3 is a
long-sought effector of ciliary PKD1/PKD2 signaling. This hypothesis is tested in two independent aims by 1)
testing whether GLIS3 is regulated by Polycystins and acts downstream of Polycystins to prevent cystogenesis
and 2) testing whether GLIS3 traffics from primary cilia to the nucleus and is regulated by ciliary signaling
mediators. This work will employing innovative approaches to study ciliary signaling to generate fundamental
knowledge about the pathways underlying cystic kidney disease.
The proposed career development plan includes training to help establish Dr. Loeb’s ability to dissect
pathways involved in genetic forms of kidney disease using mouse models, organoid models, and advanced
imaging. In addition, the training plan will help Dr. Loeb develop all the non-experimental skills necessary for a
career as a successful independent academic investigator. These additional skills include laboratory
leadership, trainee mentoring and supervision, and grant writing. Dr. Loeb has assembled a world-class
mentorship team with complementary expertise in mouse models and ciliary signaling (Primary mentor, Dr.
Jeremy Reiter), imaging and ciliary ion channels (Co-mentor Dr. Markus Delling), organoids and kidney
disease models (Advisory Committee Member Dr. Andrew McMahon), Ciliary biochemistry and protein
analysis (Advisory Committee Member Dr. Maxence Nachury), Polycystic Kidney Disease (Advisory
Committee Member Dr. Meyeon Park), and human genetics and single-cell genomics (Dr. David Erle). Dr.
Loeb, his mentors, and the Department of Medicine at UCSF are fully committed to this proposal and to his
goal of becoming an independent scientist-nephrologist by the completion of this training period.

Public health relevance
PROJECT NARRATIVE Autosomal Dominant Polycystic Kidney Disease is caused by mutations in Polycystins which localize to the primary cilium. This proposal tests the hypothesis that GLIS3 is an effector of ciliary Polycystin signaling and will generate fundamental insights into mechanisms underlying cystic kidney disease.